Nanogenerator-Driven Self-Sustainable Power Source for Intracardiac Pacemakers

Project Summary:
Revolutionary advancements in pacemakers include a miniaturized and leadless design and intracardiac
implantation. However, the bulky and rigid battery creates the largest hurdle towards further development of a soft
system that can be attached and conform to tissue and muscle surfaces without causing unwanted physiologic
changes. To address this critical challenge, this project proposes to develop a self-sustainable power source
(SSPS) for intracardiac pacemakers using swine models. The SSPS integrates a stretchable, frequency-tuning
implantable nanogenerator (i-NG) with a miniaturized supercapacitor and regulating electronics, which can
automatically and consistently power a pacemaker by harvesting energy from heartbeats.
This project is led by Dr. Wang (PI), with Drs. Hacker and Liu as the co-Is and a cardiac surgeon Dr. Osaki as
collaborator, for the development of a flexible i-NG to harvest energy from biomechanical sources. Previous work from
Wang and Hacker has confirmed the long-term stability of i-NGs and their negligible impacts on normal heart functions
when sutured on swine hearts. Wang has also developed a flexible, micro-grating i-NG capable of converting slow
organ motion to continuous alternating current (AC) electricity desired for efficient capacitor charging. Building on
these supportive preliminary results, this project focuses on designing and validating a SSPS specifically for powering
intracardiac pacemakers by harvesting energy from heartbeats. In Specific Aim 1, we will develop a stretchable SSPS
that integrates a flexible i-NG with a commercial supercapacitor and regulating electronics. The membrane i-NG can
convert heart beats into continuous, high-frequency AC electricity with an output voltage suitable for efficiently
charging the supercapacitor. In Specific Aim 2, we will investigate the bio- and hemo-compatibility of SSPS ex vivo
and test the SSPS device in a simulated intracardiac environment. In Specific Aim 3, we will characterize electrical
output of SSPS in vivo epicardially in different locations and orientations on the epicardial surface of the right ventricle
(RV) of swine hearts. Cardiac function will be monitored over time to ensure SSPS implantation does not alter heart
function. The ability to power a commercial pacemaker will also be tested in vivo. In Specific Aim 4, we will investigate
intracardiac implantation of SSPS on the internal RV free wall of a surgically removed and beating swine heart on a
Langendroff apparatus to test the intracardiac operation ex vivo.
This proposed research will develop a novel intracardiac energy harvester that is self-sustainable by harvesting
biomechanical energy from heartbeats. Success of this research will establish a technology framework necessary to
move rapidly to in vivo intracardiac implantation and testing of SSPS for powering intracardiac pacemakers . This
intracardiac energy harvesting technique will present an unprecedented engineering solution to address the power
supply challenges for the next generation intracardiac pacemakers by altering flexibility, decreasing size, improving
safety, and eliminating the battery component.

Public health relevance
Project Narrative This proposed projectdevelops a self-sustainablepower source (SSPS) for intracardiacpacemakers using swine models. The SSPS integrates a stretchable, frequency-tuning implantable nanogenerator with a miniaturized supercapacitor and regulating electronics, which can automatically and consistently power a pacemaker by harvesting energy from heartbeats. This project will establish the technology framework necessary to move rapidly to in vivo intracardiac implantation and the testing of SSPS for powering intracardiac pacemakers.